Transdisciplinary Training at the Intersection of Environmental Health Science and Social Science (EH+SS)

The goal of this first T32, 5-year renewal of the successful “Transdisciplinary Training at the
Intersection of Environmental Health and Social Science” is to prepare 10 doctoral students and
8 postdocs (4 environmental health and 4 social science) to be future leaders in social science environmental health science collaborations. This overall goal has the following objectives:
1) Educate trainees in a new research trajectory that combines environmental health and social
science; 2) Teach trainees about community-based participatory research (CBPR),
informal science education, and public participation in research; 3) Train researchers to integrate
CBPR practices into existing and emerging research programs; 4) Provide hands-on training at a
science-based community-based organization (CBO) to demonstrate to trainees how it does
research and interfaces with advocacy on emerging contaminants and technologies. This training
program is unique in that is co-directed by an academic institution – Northeastern University's
Social Science Environmental Health Research Institute and a non-academic institution - Silent
Spring Institute, a science-based environmental non-profit organization. It builds upon 15 years of
collaborative research and training activities between the two partners. Trainees are equipped to
improve environmental health through: core and elective coursework, two dedicated seminar
series for trainees, engagement with CBOs that use novel tools for robust exposure and dose
estimates, participatory research methods such as community-based participatory research and
civic science, and reflexive research ethics. Trainees will be part of research teams at both
institutions, including processes and ethics of reporting back biomonitoring and personal
exposure results to participants; data sharing and privacy protection; exposure, remediation,
health effects, and regulatory and policy issues of per- and polyfluoroalkyl substances, modeling
of emerging contaminants in Cape Cod drinking water, water access and equity; development of
exposure biomarkers for breast cancer studies; and development and application of low-cost
community sensors. Trainees will also learn how to work with the news media. Pre-doctoral
trainees will be funded for 3 years each, and the postdoctoral trainees will be funded for 2 years
each.

Public health relevance
Title: Transdisciplinary Training at the Intersection of Environmental Health and Social Science Project Narrative: This renewal of the successful “Transdisciplinary Training at the Intersection of Environmental Health and Social Science” prepares 10 doctoral students and 8 postdocs to be future leaders in social science-environmental health science collaborations. This training program is uniquely co-directed by an academic institution - Northeastern University and a non-academic institution - Silent Spring Institute, a science-based/community-based participatory research environmental non-profit organization. Trainees will have coursework and skills sessions at NU, research projects at both NU and Silent Spring Institute, and visits to laboratories and community groups.